Magnetic Resonance Imagery Study Of Avascular Necrosis O

In 2002 we reported the occurence of avascular necrosis of bone (usually the hip) in 15 asymptomatic patients with HIV disease. We are currently assessing the natural history of avascular necrosis in this chart and in an additional ten patients with symptomatic disease. The occurence of pain and functional disability is being assessed. The development of AVN at other sites is also being evaluated by yearly MRIs. The study will elucidate natural history and risk factors for this unexpected complication of treated HIV disease.